Dopaminergic modulation of NMDA receptor signaling in the Nucleus Accumbens

Project Summary
Alterations in both dopamine (DA) and glutamate signaling in the Nucleus Accumbens (NAc) are thought to play
a key role in substance use disorders and addiction. DA regulates NAc circuit activity by modulating glutamatergic
transmission and receptor activity, however, the precise mechanisms remain unclear. Synaptic plasticity and
regulation of intracellular excitability is primarily attributed to the functions of glutamatergic NMDA recept ors
(NMDARs). How dopamine receptors regulate NMDAR activity and how this differs between synaptic
connections in accumbal circuitry remain important questions. This proposal will utilize ex vivo slice
electrophysiology in combination with optogenetics and iontophoresis in transgenic mouse lines to investigate
the synapse specificity and intracellular signaling mechanisms underlying DA receptor regulation of NMDAR
current in both D1 and D2 type dopamine receptors. Understanding the synergistic role of D1 and D2 receptor
signaling in regulating glutamate transmission and receptor activity in the NAc is a critical step in the investigation
of both motivation and the dysfunctions that arise in this system after exposure to drugs of abuse.

Public health relevance
Project Narrative Understanding how dopaminergic signaling regulates neuronal activity is essential to understanding how brain reward circuits become altered as a result of chronic drug use. Dopamine receptor signaling importantly tunes the activity of glutamatergic NMDA receptors to regulate neuronal excitability, yet the exact mechanisms underlying dopamine receptor modulation of NMDA receptors remains unclear. A better understanding of dopamine-glutamate interactions has the potential to identify new strategies for investigating substance use disorders.